Administrative Core

Abstract
The specific aims of our Center require diverse experts who interact closely and bring
complementary expertise to the project. We have assembled a group of investigators
that span the necessary sub-disciplines and have a history of working together. The
Administrative core of the Center for Pediatric Tumor Cell Atlas (CPTCA) will be co-led
by Dr. Tan and Dr. Hunger. Administrative oversight of the Center will be provided by an
internal Executive Committee. The daily operation will be managed by a dedicated
Center Administrator. The Executive Committee has extensive experience in various
aspects of tumor atlas construction, including organizing multicomponent program
project grants, clinical oncology, clinical trials, cancer biology, genomics, single-cell
technologies, statistics, bioinformatics, and systems biology. The Executive Committee
will be advised in its decision making by an Internal Advisory Board (IAB) and an
External Advisory Board (EAB). The Administrative Core will support the administrative
management and research coordination of the CPTCA via the following five specific
aims: 1) To optimize interactions among Center investigators through regularly
scheduled meetings; 2) To facilitate interactions with other Human Tumor Atlas Network
(HTAN) research centers, the HTAN data coordinating center, the HTAN tissue
coordination center, and NCI; 3) To ensure timely reporting to NIH and compliance with
NIH regulations regarding sharing of data and resources; 4) To solicit, fund, and monitor
collaborative projects; and 5) To support enrichment programs for single-cell
technologies in cancer research. Risk will be mitigated through flexible planning and
progress review, including shifting budgets and resources. The IAB, EAB, and the HTAN
steering committee will be used to guide planning.